Mechanism and Therapeutic Targeting of TRIM29-mediated Invasion in Bladder Cancer

Over 17,000 will die from bladder cancer in the U.S. this year. While most patients with noninvasive tumors are
cured, most patients with muscle-invasive disease will develop metastases and die. Therefore, understanding
and targeting the molecular driver(s) which facilitate this invasive switch is essential to improve patient
outcomes. TRIM29 is a critical driver of bladder cancer initiation, invasion and therapeutic resistance in human
tumors and mouse models. TRIM29 promotes tumor formation by regulating protein interactions that govern
beta-catenin and miRNA activity. TRIM29 impacts therapeutic resistance by regulating ubiquitination of DNA
repair and innate immune pathways. The specific mechanism by which TRIM29 drives invasive progression
remains poorly understood. Rationale: Emerging evidence from our lab has identified a novel function of
TRIM29 in the regulation of intermediate filaments, focal adhesion and FAK/Src signaling. However, we do not
yet understand how this TRIM29-focal adhesion axis is regulated, how it participates in progression from non-
invasive to invasive cancers in vivo or how it coordinates with previously identified mechanisms to promote
invasive progression. This is a critical gap in knowledge because without a clear understanding of these
events, we are unable to develop therapeutic strategies to target this pathway and prevent progression to the
lethal invasive form of bladder cancer. The specific objective of this proposal is to identify the role of this novel
TRIM29-focal adhesion axis in invasive progression and to use this knowledge to develop therapeutic
strategies to block invasive progression in high-risk TRIM29+ tumors. The central hypothesis is that TRIM29
drives progression from noninvasive to lethal invasive bladder cancer by driving intermediate filament
and focal adhesion formation, and activation of FAK/Src signaling in invasive cells. This hypothesis will
be tested in the following specific aims: 1) To conduct detailed structure-function analysis of the TRIM29
interaction with intermediate filaments, the focal adhesion complex, and FAK/Src signaling during invasion. 2)
To determine the requirement for TRIM29, KRT14, and focal adhesion proteins during bladder cancer initiation
and invasive progression. 3) To evaluate novel therapeutic strategies to block TRIM29-mediated invasion in
bladder cancer. Aim 1 will utilize live cell imaging, 3D and animal models of invasion. Aim 2 will leverage
unique GEMM of bladder cancer to dissect the essential functions of TRIM29 in vivo. Aim 3 will use our
multiple models to identify therapeutic strategies to target TRIM29-mediated invasion. This research is
conceptually innovative in the characterization of a novel TRIM29-focal adhesion pathway of invasive
progression and technically innovative in the development of novel bladder cancer murine models, advanced
3D tumor invasion assays and novel therapeutic targeting strategies. The proposed research is significant
because description of the mechanism of TRIM29-mediated invasive progression will allow identification of
novel therapeutic strategies to block development of lethal invasive progression in bladder cancer.

Public health relevance
The proposed research is relevant to public health because it is focused on identifying how TRIM29 promotes bladder cancer invasive progression and metastasis. This information is likely to identify biomarkers which may allow early detection of invasive/metastatic potential and novel therapeutic targets, both areas of unmet need in the bladder cancer field. This proposal is directly responsive to the NCI mission and specifically responsive to FOA: PAR-19-183 Biology of Bladder Cancer, which identifies “Mechanistic understanding of bladder cancer invasion and metastasis,” and “Developing and validating new human relevant models of bladder cancer” as key areas of interest.